Cancer Center Administration

ABSTRACT: The purpose of the UNMCCC Administration (Admin) Core is to provide administrative leadership oversight of and support for all aspects of the expanding cancer research and clinical research enterprise throughout the University of New Mexico Health Sciences Center (HSC), other New Mexico Universities and UNMCCC consortium partner, LRRI. The Admin Core facilitates and promotes transdisciplinary collaborations among the 102 Cancer Center members as well as with other NCI Centers and academic institutions. Associate Director for Administration Rae Ann Paden, MPH, is responsible for administrative functions within the UNMCCC, as well the integration of UNMCCC activities through interactions with the administrations of the UNM School of Medicine and Health Sciences Center (HSC). Paden coordinates the activities of Cancer Center Research Administration (CCRA) directed by Ms. Erin Fitzgerald, MBA, and the Clinical Research Office managed by Valerie Parks, BSN, CCRP. Key accomplishments over the past 5 years include; • Facilitated the strategic recruitment of 33 new Cancer Center members and 21 cancer-focused clinical faculty • Established the UNMCCC Office of Community Outreach and Education and the cancer Research Training and Education Co-ordinating Core • Organized and monitored the UNMCCC pilot grant program that awarded 107 pilot grants resulting in over $26 million (direct cost) in funding from national funding agencies • Supported the re-organization of the clinical research infrastructure • Implementing electronic reporting tools for essential Cancer Center data metrics In the next grant cycle, Admin Core functions will include; 1) supporting Cancer Center strategic planning and evaluation activities; 2) overseeing membership application and evaluation processes; 3) supporting UNMCCC Research Programs by scheduling and staffing meetings and annual retreats; 4) preparing CCSG budget and monitoring of CCSG expenditures; 5) preparing CCSG progress reports and renewal application; 6) maintaining CCSG-relevant databases, including membership, extramural funding, shared resource usage and CCSG- supported publications; 7) overseeing use of CCSG Developmental Funds, assisting in the development of requests for pilot grant proposals, facilitating the review of pilot project applications and tracking outcomes; 8) coordinating the annual UNMCCC External Advisory Committee meeting, UNMCCC retreats, meetings, and workshops; 9) supporting UNMCCC Shared Resources by tracking usage, generating invoices, and implementing the co-pay mechanism; 10) coordinating seminar series, including the Director's Lectureship series; and 11) disseminating notices of research events and external and internal funding opportunities to all UNMCCC members.